GENETIC ASPECTS OF MULTIPLE ENDOCRINE NEOPLASIA, TYPE 2A

The purpose of this study is to 1) screen members of a family for multiple endocrine neoplasia, Type 2A and determine which members have Lichen Amyloidosis; 2) develop lymphoblast preparations from family members and spouses to be used in genetic linkage studies; 3) characterize the lichen amyloidosis lesion and determine the protein in the amyloid lesion; and 4) develop better techniques for prospective screening of pheochromocytoma in men 2A.